Understanding how chromosomal makeup and cross-sex hormone administration affect wound healing in mice

Project Summary
Transgender individuals experience persistent psychological distress caused by an incongruency
between one’s assigned sex at birth and one’s internal sense of self. For transgender males (i.e., assigned
female at birth and identifying as male), medical treatment can involve administration of lifelong exogenous
testosterone (T) and/or gender affirming surgery (GAS). It is estimated that over one million individuals in the
United States currently identify as transgender, and demand for GAS has increased over the past two decades.
As more of these procedures are performed, a handful of reports have recently started trickling in claiming that
there are worse healing outcomes among transgender male patients, but the breakdown of transgender males
who were on T versus not on T at the time of surgery was not elucidated by these reports.
Co-Sponsor Dr. Devin O’Brien-Coon is a plastic surgeon who performs GAS and observed this same
phenomenon and hypothesized that presence of T perioperatively may be playing a role in mediating wound
healing in this patient population. To validate these observations, the Coon lab conducted an assessment on
148 transgender male patients (XX-chromosome individuals, some on T and some not on T) showing statistically
significant differences in grading of wounds and scars between both groups. Meanwhile, no disparity is observed
between transgender females (who take estrogen and suppress T) and cisgender females.
We hypothesize that T may modulate wound healing in a more complex manner than the scientific
community had understood up until this point by shifting cell phenotypes and operating under novel pathways,
with sex chromosome- and sex hormone receptor-dependent effects, and by preferentially affecting immune
cells. We will test these hypotheses using various assays including planimetry, histology, immunofluorescence,
flow cytometry, single cell RNA sequencing, transgenic mouse models, and chemical and genetic depletion. By
performing these experiments, we will obtain wound healing metrics such as comparing collagen deposition,
granulation tissue, wound area remaining, localization of cell phenotype markers, identifying causal pathways,
gene expression, involvement of the Y chromosome and Sry testes-determining gene, and immune cell
quantification and visualization.
Successful completion of these aims will give us a new understanding of the biological mechanisms
responsible for this observed impaired wound healing in transgender men, who undergo lifelong T therapy, and
has the potential to significantly rewrite perioperative guidelines for gender affirming surgery. By filling this
knowledge gap, this research may ultimately offer improved wound healing and personalized medicine therapies
to not only transgender patients but all patients.

Public health relevance
Project Narrative Transgender male patients (i.e., assigned female at birth and identifying as male) who undergo gender affirming surgery while on masculinizing testosterone replacement therapy have been reported to have worse scarring and wound healing outcomes compared to those not on testosterone at the time of surgery. Using a variety of cutting-edge techniques, this research will investigate the biological mechanisms responsible for this phenomenon, leading to improved understanding of wound biology and the potential to rewrite perioperative guidelines.